Project 4: Single-molecule studies defining molecular and cellular requirements for Pol θ

PROJECT SUMMARY: PROJECT 4
This project will investigate mammalian DNA polymerase θ (Pol θ), the defining enzyme for repair of DNA double-
strand breaks by polymerase theta-mediated end joining (TMEJ). This is Project 4 (“Single-molecule studies of
molecular and cellular requirements for Pol θ”), part of a Program Project titled, “Polymerase theta, genome
instability, and cancer”. TMEJ is a mutagenic double-stranded break (DSB) repair process vital for cell survival
and therapeutic resistance in cancer, particularly those deficient in homologous recombination (HR) repair, such
as BRCA-mutated cancers. Despite its significance as a potential cancer therapeutic target, key mechanistic and
functional aspects of TMEJ remain poorly understood, hindering the effective application of targeted therapies.
This project aims to fill several fundamental gaps in our knowledge of TMEJ, and explore novel hypotheses by
employing an array of innovative biochemical, cellular, and single-molecule techniques and assays to define the
key steps and molecular mechanisms of TMEJ. First, we will use biochemical reconstitution and single-molecule
assays to investigate some of the key interactions and mechanisms of Pol θ that occur during repair junction
formation and later processing steps. Second, we will define the role of Pol θ in the repair of single-ended DSB
fork lesions induced by Top1i and its crosstalk with the HR pathway. Third, we will determine Pol θ involvement
in suppression of endogenous replication fork damage and replication conflicts.
In Aim 1 “Mechanism of TMEJ Repair via Biochemically Reconstituted System” we diverge from the current
DSB-centric view of TMEJ by investigating its role in repairing fork lesions, by defining the distinct configurations
and molecular requirements involved in repair junction formation, while also investigating the mechanism of its
exchange with Pol δ and crosstalk with HR proteins.
In Aim 2, “Crosstalk of Pol θ and HR in the Repair of Collapsed Replication Forks”, we will test the hypothesis
that Pol θ actively participates in repairing Top1i lesions, and possibly distinct subsets of such lesions that might
permit a crosstalk with HR leading to TMEJ when HR is deficient upon BRCA loss.
In Aim 3, “Deciphering Pol θ's Role in Suppressing Endogenous Replication Damage”, we will explore the
roles that Pol θ plays in suppressing endogenous fork damage at genomic regions prone to persistent replication
barriers and breakage, particularly those associated with G4 structures, and test whether the accumulation
and/or persistence of such unresolved lesions may underlie the synthetic lethality of Pol θ with several factors.
The proposed studies are built on our achievements and developments made in the course of the current
funding period, and incorporates new observations, reagents and experimental tools that were derived jointly
with the other projects and cores. Our combined diverse approaches include molecular biology, biochemistry,
structural biology, and biophysics. Substrates, proteins, and experiments will be designed with Projects 1, 2, and
3, and will be constantly monitored with feedback via Core A. Protein purification will be supported by Core B.

Public health relevance
PROJECT NARRATIVE: PROJECT 4 The limitations in our understanding of polymerase theta protein functions directly affect our approaches to the treatment of human cancers. This project is highly significant because it examines complex levels of polymerase theta meditated repair that have relevance to aberrant DNA repair and replication in cancer. Our proposal addresses key issues that are directly related to therapeutic response and resistance in cancer.